Molecular and serological surveillance of SARS-CoV-2 in companion and food animals, USA

Project Abstract/Summary
Molecular and serological surveillance of SARS-CoV-2 in companion and food
animals, USA
Monitoring SARS-CoV-2 infections in animals is crucial for better understanding
the virus and its potential for transmission between species. The virus has already been
shown to infect a range of animals, including minks, dogs, and cats. By monitoring animal
infections, potential reservoirs of the virus can be identified and new strains that may be
more transmissible or virulent can be prevented. Additionally, monitoring animal infections
ensures the safety of both animal and human populations by identifying and controlling
infections in animals.
In this study, we will perform PCR and ELISAs to detect SARS-CoV-2 virus and
antibodies in nationwide collected dog samples (n=800), cat samples (n=800), and in
horse (n=200) and cattle (n=200) samples from Alabama. SARS-CoV-2 Reverse-
Transcription FRET-PCR will be performed to detect the virus, followed by DNA
sequencing and whole-genome sequencing. The ID Screen® SARS-CoV-2 Double
Antigen ELISA and SARS-CoV-2 Surrogate Virus Neutralization Test (sVNT) will be used
to detect antibodies against SARS-CoV-2 infection, and positive and questionable
samples will be sent to the United States Department of Agriculture (USDA) National
Veterinary Services Laboratories (NVSL) for SARS-CoV-2 virus neutralization tests to
confirm results.
Monitoring animal populations for SARS-CoV-2 infections is essential to prevent
the spread of the virus to humans and identify potential reservoirs of the virus. This study
will also help to understand the epidemiology of SARS-CoV-2 in dogs, cats, and horses,
as well as food animals in the USA.

Public health relevance
Project Narrative The aim of this study is to screen convenience samples taken from companion and food animals using PCR and ELISA methods, with the purpose of determining the prevalence of SARS-CoV-2 and identify the types of variants /subvariants present.